Effect of Human Milk Oligosaccharide-based synbiotics on neurodevelopment of HIV-exposeduninfected children

ABSTRACT
This is a request for supplement funding to the MIGH-T MO study (i.e. R01HD105492 titled: “Trial of Human
Milk Oligosaccharide-based synbiotics for HIV-exposed uninfected children”) being conducted in South Africa.
This supplement study is related to the parent study aims of studying the effect of the intervention on outcomes
of growth and morbidity, by focusing on neurodevelopment. Neurodevelopment is an important part of growth
and morbidity, thus relevant to the parent study aims. Of relevance to the parent study population of children
who are HIV-exposed uninfected (CHEU), there is data from multiple settings including South Africa that show
impaired neurodevelopment in CHEU compared to children who are HIV-unexposed uninfected (CHUU), and
an intervention to improve neurodevelopment outcomes are currently lacking for CHEU. Importantly, animal
model data and observational data from humans suggest that certain human milk oligosaccharides, such as 2’-
Fucosyllactose being used in this study, are positively associated with neurodevelopment. Thus, our study
provides an important opportunity to test the effect of the human milk oligosaccharide-based intervention on
CHEU neurodevelopment using a randomized trial design. Overall, we hypothesize that the intervention will
improve neurodevelopment in CHEU. Our findings would inform on whether the synbiotic could be an effective
intervention to reduce growth deficits and morbidity, as they relate to neurodevelopment, in CHEU.

Public health relevance
NARRATIVE In an ongoing randomized-controlled trial in South Africa, we are currently testing the effect of a human milk oligosaccharide-based synbiotic on child growth and morbidity. In this study, we propose to supplement the goals of the parent trial by studying whether the intervention impacts child neurodevelopment, an important component of growth and morbidity. This study would inform on whether this synbiotic intervention reduces growth deficits and morbidity as it relates to neurodevelopment.